Experimental Irradiation (EI)

PROJECT SUMMARY/ABSTRACT (EXPERIMENTAL IRRADIATION)
The Experimental Irradiation (EI) Shared Resource (SR) provides access to state-of-the-art equipment
and expert consultation for University of Michigan Comprehensive Cancer Center (UMCCC) members
undertaking radiation therapy studies in mouse models and cell lines. First established in 1991, this SR
has been approved and funded continuously by the NCI CCSG since its inception. At the last CCSG
renewal, the EI SR received a merit rating of “Outstanding.” The services of this SR are critical to
members interested in radiation biology and radiation therapy, as well as those for whom radiation serves
as a research tool.